Brain Imaging Core

Waisman Center investigators study intellectual and developmental disabilities (IDD) through investigating the
brain structure and function in both animal models and individuals exhibiting or at risk for these conditions. The
Waisman Brain Imaging Core (BIC) provides all of the tools and services required for these investigations and
includes facilities for magnetic resonance imaging (MRI), human positron emission tomography (PET), high-
resolution PET for animal imaging, ancillary physiological recordings during imaging, and extensive software
tools and training for image analysis. This facility occupies a key role in providing systems level neuroscience
that lies at the interface between the neurodevelopment, behavioral and molecular levels of analysis. The specific
aims for for the Brain Imaging Core are: Aim 1 to develop MRI, PET, fNIRS hardware, methodologies and
software technologies for neuroimaging studies of normal development, atypical development, and
neurodegeneration in both humans and animal models. The objectives of this aim encompass all of the available
neuroimaging modalities and resources available for IDD investigators. We also provide access to a highly
realistic MRI simulator to enable participants to acclimate to the procedures and rehearse the behavioral
protocols that are used in scanning. Aim 2 to provide expertise and guidance for neuroimaging protocol
development and experimental design to UW-Madison investigators for studying IDD populations and animal
models. The objectives of this aim are to ensure IDD investigators have access to technical expertise in
neuroimaging methods as they plan, initiate and conduct their research projects. The BIC is staffed with highly
skilled imaging scientists with expertise in MRI pulse sequence design, PET neuroreceptor imaging,
radiopharmaceutical development, rodent and nonhuman primate imaging and data analytics. Aim 3 to provide
training and technical support for investigators and their staffs in the use of all of the imaging modalities in the
BIC. The objectives of this aim include the conduct of courses and training workshops, regular technical updates
at BIC monthly meetings and lab meetings of the participating PIs, specialized consultation with the staff and
students of PIs, development of specialized scanning sequences and data acquisition protocols for novel
applications and consultation and support in statistical analysis of imaging data. The overall activities and
function of the BIC will be directed by the goal of enriching the UW neuroscience community to disseminate
ideas, implement plans and train neuroimaging scientists for research in IDDs.